Administrative Core

PROJECT SUMMARY (See instructions): The Administrative Core will be responsible for the general administration of the Program Project grant. It will continue to be headed by Dr. Gregory Harshfield and Dr. David Pollock. The Core will also include individuals with supervisory responsibility over the reseach staff for the human components of each project. These include:1) the processing of human samples; 2) subject recruitment and IRB approvals; and 3) nursing supervision for the pharmacologic studies.

Public health relevance
These activities will assure the Program Project grant will meet the goal of providing new and valuable information which can be translated into improved strategies for the prevention and treatment of essential hypertension